Gene-environment interaction in islet serotonin metabolism and impacts on maternal glucose homeostasis

ABSTRACT
Gestational diabetes is characterized by chronic maternal hyperglycemia during pregnancy without a prior
diagnosis of diabetes. It is a very common obstetric complication affecting ~10-25% pregnant women globally.
Because women with gestational diabetes are more likely to have other pregnancy complications, deliver large
for gestational or premature babies, and develop type II diabetes, gestational diabetes poses a serious threat
to the health of mother and baby. Although some risk factors have been defined, the underlying mechanisms
are complex and the precise etiologies are poorly understood. Recent studies show that pancreatic serotonin
signaling plays a critical role in maternal glucose homeostasis. Increased serotonin synthesis in the pancreatic
islet is a critical event that promotes beta cell proliferation and increased insulin secretion that are needed to
prevent maternal hyperglycemia during pregnancy. Dietary and genetic factors that reduce islet serotonin
synthesis are causatively linked to gestational diabetes in mice. Our preliminary studies show that low dose
exposure to perfluorooctanoic acid (PFOA) is associated with reduced abundance of serotonin and its critical
cofactor vitamin B6 in the pancreas from pregnant C57BL/6 mouse. These results are consistent with
epidemiological findings that PFOA exposure in pregnant women is linked to maternal hyperglycemia, insulin
resistance, and glucose intolerance. Interestingly, DBA/2J mice exposed to PFOA do not develop gestational
diabetes. The C57BL/6 and DBA/2J mice differ in their abilities to metabolize vitamin B6 due to differences in
activities of alkaline phosphatase (ALP). These results suggest that environmental exposure-induced
gestational diabetes is modulated by genetic background and higher endogenous vitamin B6 level confers a
protection. The overall hypothesis is that PFOA exposure in pregnant mice is causatively linked to gestational
diabetes through mechanisms that perturb serotonin metabolism in maternal pancreatic islets and the effects
are modulated by genetic differences in vitamin B6 bioavailability. We propose to investigate beta cell
proliferation and serotonin abundance in control and PFOA-exposed pregnant C57BL/6 mice to determine
whether the gestational diabetes is causatively linked to reduced beta cell expansion and reduced insulin
secretion. We also wish to investigate whether treatment with an ALP inhibitor in the DBA/2J pregnant mice will
reduce vitamin B6 in pancreatic islets and result in loss of protection to gestational diabetes. Finally, to
determine how pregnancy and gestational diabetes influence islet programming, we will perform RNA
sequencing and Cleavage Under Targets and Tagmentation followed by sequencing to study changes in the
transcriptome and epigenome in response to physiological changes and disease. The proposed research will
provide knowledge on mechanisms underlying gestational diabetes that benefit public health.

Public health relevance
PROJECT NARRATIVE The proposed application will use the mouse model to investigate how exposure to perfluorooctanoic acid (PFOA) adversely influences maternal glucose homeostasis during pregnancy. Human studies suggest that PFOA exposure is associated with increased risk for gestational diabetes, however these observations have not been validated experimentally and the underlying mechanisms are not well understood. In this work, we will define how exposure to PFOA disrupts serotonin metabolism in maternal pancreatic islets and how genetic differences in vitamin B6 metabolism modulate the susceptibility to PFOA-induced gestational diabetes in pregnant mice.